Neurofeedback Impact on Chronic Headache, Sleep and Attention Disorders Experienced by Veterans with Mild Traumatic Brain Injury.

War has led to many disabling health challenges among our Veterans. One very significant challenge is
traumatic brain injury (TBI) which resulted from Veterans’ exposure to improvised explosive devices (IEDs)
during the Iraq and Afghanistan conflicts. Although the effects of most mild (m)TBIs resolve in days or weeks, a
significant number of our Veterans, estimated at 23-48%, have persistent symptoms relating to their mTBI that
impact daytime functioning, ability to work, mental and physical wellness and quality of life. Since treatment
options are limited for this disorder and its persistent symptoms, new viable treatment strategies need to be
studied. Neurofeedback (NFB) has been shown to affect cortical neuroplasticity and contribute to neuro-
neuronal rehabilitation by changing connectivities of specific areas of the brain that may have been impaired
and these changes appear to be permanent. Over 25 case and small studies have provided evidence that
NFB, which uses brain wave feedback strategies via gaming simulations, has led to a variety of improved mTBI
outcomes. The next logical step is to conduct a clinical trial to provide further support that NFB can impact
persistent post concussive symptoms that are experienced by Veterans.
The study’s objective will be to evaluate NFB training as a low risk, non-invasive, effective treatment for our
Veterans who had an mTBI, also referred to as concussion, while serving in the military. The particular chronic
post-concussive symptoms targeted will be headache, insomnia, and attentional difficulties. Perceived quality
of life will also be assessed pre and post intervention. It is hypothesized that when compared to the control
group that receives usual standard care, those Veterans who receive NFB training, along with usual standard
care, will have: 1) greater reduction in the frequency, duration, and/or severity of headaches; 2) greater
improvement of sleep efficiency and/or perceptions of quality of sleep; 3) more improved attention; and 4)
improved perceptions of quality of life.
Specific aims will be to compare the NFB treatment group (receiving 20, 1-hour sessions plus usual care) with
a control group (receiving only usual care) on improvement in clinical symptoms (insomnia, headaches,
attention difficulties and quality of life) as ascertained by the study instruments’ (that measure the clinical
symptoms) scores at baseline, midpoint, end of treatment and 2-month follow-up.
Study Design: This study will utilize a randomized control group design that includes a delayed post-control
intervention group to assess the impact of NFB on headaches, insomnia, attention difficulties, and quality of
life. Seventy-two Veterans with a deployment related mTBI who are experiencing headaches, insomnia, and
attention difficulties will be enrolled, 36 in the NFB treatment group and 36 in the control group. After control
group members complete the final assessment, they will be offered NFB. Thus, a total of 72 Veterans
(intervention and post-control) who complete all NFB sessions and evaluations will be the sample for this
project. Data will be analyzed between groups (intervention and control) and within the intervention groups.
Impact: The experience of headaches, insomnia, and attention difficulties can lead to debilitation in all areas of
Veterans’ lives. This project will provide evidence for the use of NFB with Veterans to alleviate their chronic
symptoms and enhance their quality of life. If supported, NFB will offer our Veterans an efficacious and non-
invasive treatment option. NFB is a patient focused intervention that enables Veterans the opportunity for self-
health management.

Public health relevance
This project will evaluate neurofeedback, a type of biofeedback, training as a low risk, non-invasive, effective treatment for our Veterans who had a concussion(s) while at war serving in the military. Some Veterans, who experienced concussions, may suffer from some long-lasting health issues such as headaches, trouble paying attention, sleep difficulties and negative feelings about their life. These can negatively impact all aspects of life, including work, health, relationships, ability to do daily tasks and quality of life. Since neurofeedback, has been shown to help other people who had concussions, this study will examine whether neurofeedback will help our Veterans. Neurofeedback will be used to assist Veterans to self-regulate brain wave activity and stabilize the underlying physiological disconnections that may stem from concussions. Assisting Veterans to self-regulate brain wave activity through neurofeedback has the potential for significant positive changes in Veterans’ physical and mental health and their perceptions of self-health management and overall quality of life.